Optical control of G protein-coupled receptor function

Project Summary
The overarching goals of my lab are to (i) develop molecular tools to control and map how subcellular signaling
influences physiology and pathology and (ii) learn from and use biological photon reception to advance molecular
pharmacology. Due to their unprecedented physiological and pathological footprint in many diseases, including
cardiovascular, metabolic, neurological, and oncological, we focus on G protein-coupled receptors (GPCRs).
Although GPCRs in individual cells in the body are controlled by spatially and temporally fluctuating ligands with
various cell membrane permeabilities, limited tools to interrogate their signaling with native fidelity have been an
obstacle to understanding their signaling regulations in health and disease. With the R01 funding support,
promising published and preliminary data we generated show the feasibility of optical control of endogenous
GPCRs and G proteins to overcome this challenge. This MIRA proposal will deliver innovative optical tools to
control endogenous GPCRs in unmodified cells and in vivo (Goal 1) and GPCRs and endogenous G proteins at
exclusive subcellular locations such as Golgi and nuclear membranes (Goal 2). It also focuses on finding
molecular links between environmental light conditions, cell signaling, and animal behavior mediated by the
melanopsin photopigment (Goal 3). Given the immense challenges in controlling deep-tissue GPCRs to
understand diseases such as neurodegeneration, the likely pathological outcomes of GPCR-G protein signaling
from endomembranes, including heart failure and addiction, and the significance of the link between
environmental light conditions with mood and behavior disorders, such as seasonal affective disorders and
depression, we anticipate that the project deliverables will be significant in deciphering pathological mechanisms
and finding disease intervention points.

Public health relevance
Project Narrative Primarily controlled by chemical stimuli, GPCRs and G proteins are central regulators of physiology (cardiac, neuro, behavioral) and pathology (cancer, addiction & depression). Therefore, precise spatial and temporal control of GPCRs is essential to understanding the molecular regulation of their functions and intervening pathological signaling. Our research seeks to reengineer the abilities of specific proteins to sense light and undergo conformational changes to optically control GPCRs in unmodified cells (Goal 1), deliver light-sensing and signaling optimized GPCRs for (a) subcellular, (b) in vivo signaling (Goal 2), and interrogate wavelength- dependent signaling underlying behaviors by the non-visual photoreceptor, melanopsin (Goal 3).